Novel warming and massaging bra for improved breast milk expression

PROJECT SUMMARY
Breast milk is an unmatched bioactive source of nutritional, immunological, and neurodevelopmental benefits
for infants that evolves as an infant grows to meet their unique health and nutritional needs. As such, breast
milk is considered the clinical gold standard for infant feeding, and both the American Academy of Pediatrics
(AAP) and the World Health Organization (WHO) recommend exclusive breastfeeding through 6 months of
age. Exclusive breastfeeding is defined as giving no other food or drink than breast milk, which can be
achieved by nursing infants at the breast, bottle feeding breast milk, or a combination of the two. At some
point, 85% of breastfeeding mothers will use a breast pump (equating to 2.56 million new mothers every year),
and a high proportion will continue regular use. A major limitation of the electric breast pump is that it singularly
uses suction power to remove milk from a breast. This can result in only removing milk closest to the nipple. An
infant, on the other hand, uses a combination of suction, the warmth of their mouths, and the movement of
their jaw and hands against the breast to efficiently and completely remove milk from the breast. Therefore,
breast pumps are missing two of the three key elements necessary for effective breast milk extraction.
Momease Solutions released a customer discovery survey on social media and received over 1200 individual
responses in 24 hours. A staggering 97% of responders reported challenges while using a breast pump, with
top challenges including long, uncomfortable, and low-yield pumping sessions. Individually, manually warming
or massaging the breasts while pumping has been shown to increase milk output by 42% and 48%,
respectively. To date, no accessory exists that introduces warmth and positive pressure massage to the breast
pump experience in a hands-free manner. To address this unmet need, Momease will seek proof-of-concept
data for their warming and massaging bra through the following Phase I Aims—Aim 1. Design and develop
novel hands-free warming and massaging bra, Aim 2: Test the bra for warming and massaging functionality,
and Aim 3: Perform usability study to evaluate intuitive operability and acceptance. Ultimately, this is the first-
step toward commercializing a technology that could make a substantial health and economic impact on the
millions of mothers and infants who seek to breastfeed through 6 months of age and beyond.

Public health relevance
PROJECT NARRATIVE Breast milk is considered the clinical gold standard for infant feeding, and both the American Academy of Pediatrics (AAP) and the World Health Organization (WHO) recommend exclusive breastfeeding through 6 months of age by nursing infants at the breast, bottle feeding breast milk, or a combination of the two. A major limitation of the electric breast pump is that it singularly uses suction power to remove milk from a breast, compared to an infant who uses a combination of suction, warmth, and pressure to efficiently and completely remove milk from the breast. Momease Solutions, Inc. intends to create an all-in-one, hands-free pumping bra that warms and massages the breasts while pumping for fast, comfortable, and effective breast milk extraction.